Non-coding Genomic Determinants of Adipogenesis

Project Summary
Cell identity is acquired by integrating multiple signaling inputs that establish complex gene regulatory
networks over time. These signals are converted into expression profiles by the binding of transcription factors
to non-coding regions of DNA known as enhancers. In human adipogenesis, multiple inputs converge onto a
single gene, PPARG. PPARG responds to these inputs through two "super-enhancers", which are dense
collections of individual enhancers. The myriad of input signals that feed into adipogenesis and drive PPARG
activation suggests the presence of complex regulatory logic within the two super-enhancers located up- and
downstream of the PPARG coding region. For instance, Creb1 is an early input in adipogenesis that appears
dispensable later, C/EBPb is required later and subsequently activates C/EBPa to maintain PPARG
transcription, and finally PPARG itself autoregulates to drive PPARG output even further, as adipocytes adopt
their terminal fate. The large genomic distances between enhancers and promoter, and the observation that
chromatin remodeling is a key bottleneck in adipogenesis suggesta hierarchical model of PPARγ activation.
We will systematically determine which functional units of the PPARG super-enhancers respond to diverse
inputs by silencing individual super-enhancer modules in a temporally resolved manner during adipogenesis.
We will combine these findings with direct observation and manipulation of chromatin contacts in single cells, in
order to test whether efficient signal transduction from super-enhancers to promoter requires 2-way
enhancer-promoter chromatin loops or complex multi-way contacts between super-enhancer modules and the
promoter.

Public health relevance
Project Narrative The largest remaining mystery in the genomic era is assigning precise function and biophysical parameters to the vast number of regulatory sequences that govern gene expression. Connecting these features to complex cellular behavior would accelerate our ability to predict phenotypic outcomes from DNA sequence alone, potentially enabling treatment options for patients with disease causing mutations found within enhancers. By combining a high-throughput temporally-resolved screen and cutting-edge DNA loci tracking combined with transcriptional imaging all within a developmentally relevant in vitro differentiation system, we will radically redefine our understanding of how enhancers activate their target genes.